Geometric and mechanical control of developmental Yap signaling

In order to build complex and structured tissues, organs and embryos during development, individual
cells need to interpret their environment and acquire appropriate cell fates at the right place and time. Failure to
do so can result in various developmental abnormalities or the emergence of cancer when cells become
unresponsive to the stops and checks imposed by their environment.
The preimplantation mouse embryo develops without any spatially pre-patterned information from the
oocyte and without any external input, making it an ideal mammalian developmental system to address how cells
interact with their surroundings to specify and maintain cell fates. The first cell fate decision is made in the context
of a mere ball of cells. Cells allocated to the surface will acquire the trophectoderm fate, becoming the progenitors
of the future placenta, and cells within the embryo will become the inner cell mass, giving rise to the embryo
proper and extraembryonic membranes. Interpreting this positional information through the presence or absence
of apico-basal polarity, which in turn dictates the activity of the conserved Hippo signaling pathway and the
subcellular localization of its effector, Yes-associated protein (YAP), was shown to play a role in driving fate
specific gene expression programs. However, YAP has been shown to be a key transducer of various mechanical
inputs in other systems, including sensing cell shape, extracellular matrix stiffness or tensile forces transmitted
by neighboring cells. Although mechanosensing has been proposed to occur during preimplantation
development, it is unclear which mechanical inputs are interpreted and whether these directly influence YAP
localization and thereby cell fate. Additionally, as most of our understanding of YAP regulation stems from the
analysis of fixed samples, how mechanical and polarity cues regulate YAP localization dynamics is not known.
Here we will use cutting-edge long term live imaging of endogenously tagged reporters of YAP and downstream
lineage markers to simultaneously measure cell shape and position, YAP localization and cell fate specific
transcription factor expression to reveal their joint dynamics. To probe the role of mechanical inputs and cell
geometry in directing YAP localization, we use various mechanical perturbations coupled with live or single cell
transcriptomic readouts. These perturbations include substituting cell-cell interactions normally experienced in
the embryo with cell-mimetic biomaterials, which can be fine-tuned to precisely manipulate geometric and
mechanical inputs a single cell receives; or applying different amounts of strain to cells to probe the effects
experienced when the blastocoel cavity forms. Finally, by using Fluorescence Recovery after Photobleaching
and protein stability measurements in live embryos, we will determine how polarity and mechanics regulate the
kinetic behavior of YAP and how YAP activity dynamics is linked to cell fate acquisition and maintenance. This
work will shed light on how a conserved signaling pathway operates to integrate multiple inputs coupling
morphogenesis with robust acquisition of cell fate in the early mammalian embryo.

Public health relevance
Narrative Cells in the developing embryo need cues from their environment to instruct them what cell type to become or when to start or stop growing and dividing. Here we will study how cells in the early mammalian embryo interpret such cues, focusing on the role of mechanical inputs, and how they process this information through the activity of the conserved signaling effector Yes-associated protein (YAP), to make an informed decision about the type of cell they should become. As mis-regulation of YAP activity is known to be frequently associated with malignant tumor formation, our work will reveal important insights into the regulation of this pathway during normal development, and serve as a basis for understanding how it goes awry in cancer.